HISTOPATHOLOGY SERVICES FOR STUDIES ON THERAPEUTICS TARGETING VIRUSES WITH PANDEMIC POTENTIAL

To support histopathology services to facilitate product efficacy testing performed under the Preclinical Models of Infectious Diseases program with a focus on viruses with pandemic potential.